Community Engagement Core

PROJECT SUMMARY (COMMUNITY ENGAGEMENT CORE)
The University of Southern California (USC) CLIMAte-Related Exposures, Adaptation, and Health Equity
(CLIMA) Center’s Community Engagement Core (CEC) will increase the capacity of intergenerational residents
from historically marginalized communities across all ages to engage in climate resiliency efforts. This will be
achieved by expanding community-academic partnerships, advancing a climate justice framework, integrating
neighborhood-level exposures (Methods Development Research Core, MDRC) and cardiovascular health and
resilience measures (two Research Projects) into dissemination activities, and developing partnerships
necessary to create an actionable community climate and health equity plans. The CEC will leverage community-
engaged and participatory strategies to advance research and understanding around the needs of communities
to address climate equity and implement a program to increase community power through increasing knowledge,
advancing local solutions, and improving dissemination of climate change research. The CEC will be guided by
the following aims: (1) facilitate an intergenerational and multi-directional communication structure that fosters
interaction, shares the Center’s research findings and engagement models with local/regional/national
audiences, and increases Center’s investigators’ understanding of community concerns, with guidance from our
community advisors; (2) build capacity of youth and residents of all ages from environmental health disparity
populations to respond to the climate crisis and associated health burdens and to address those burdens through
community science and public policy; (3) disseminate CLIMA Center research findings to local/national
audiences by utilizing innovative communication methods, tailoring print, audio, and web-based materials and
resources for intended audiences and amplifying our reach through strategic social media communication efforts;
and (4) evaluate the success of CEC activities using several key benchmarks, including (a) engagement of
residents and community-based organizations; (b) youth fellows’ professional trajectories; (c) communication
and dissemination metrics and (d) CEC integration with Center investigators.